Training Veterinarians for Careers in Biomedical Research

PROJECT SUMMARY
Veterinarian scientists play crucial and integral roles in biomedical research by developing,
characterizing, and using animal models to study human diseases, enhancing rigor and
reproducibility. Building on the outstanding foundation in comparative pathophysiology and
medicine provided by DVM/VMD training, providing in-depth, rigorous training in biomedical
research is essential to foster research careers for veterinarians. This renewal proposal seeks
continued support for our highly productive NIH- funded T32 program, led by Joseph L.
Mankowski, DVM, PhD, to train veterinarians in biomedical research at the Johns Hopkins
University School of Medicine. The primary goal of our program is to launch the careers of
veterinarian-scientists. We request funding for six DVM/VMD trainee slots/year to provide 3
years of support/trainee. At Johns Hopkins, veterinarian trainees pursue research-intensive
training by completing either PhDs or research postdoctoral fellowships if they enter the
program holding dual degrees (both DVM/VMD and PhD). We have a deep applicant pool to
draw from to fill these positions. Our training program offers an outstanding career development
opportunity for veterinarians passionate about building careers in biomedical as innovators and
leaders. The great majority of our trainees pursue either research-intensive or research-related
careers after completing training.

Public health relevance
PROJECT NARRATIVE Veterinarian scientists play crucial roles in biomedical research by developing, characterizing, and applying animal models to study human and animal diseases, thereby enhancing scientific rigor and reproducibility. Our training program offers an outstanding career development opportunity for graduate veterinarians passionate about building careers and developing as leaders in biomedical research. This proposal seeks renewal of support for our highly productive NIH-funded T32 program led by Joseph L. Mankowski, DVM, PhD, to train veterinarians in biomedical research at the Johns Hopkins University School of Medicine.